A novel role for astrocyte-secreted synaptogenic factor Hevin/SPARCL1 in microglia-mediated synaptic pruning in response to visual experience

ABSTRACT
Synaptic circuits underlie behavior and cognition in higher animals. Proper establishment and maintenance of
these circuits requires a balance in the number of connections formed and removed early in life. Increasing
evidence suggests that impaired synapse formation and elimination contribute to the synaptic pathologies
found in many neurological disorders. Rigorous in vitro and in vivo work from our lab and others have
demonstrated the critical role for astrocytes and microglia in mediating synapse formation and elimination,
respectively. Further work in the field has begun to describe how these two glial cell types may communicate
to balance synapse formation and elimination. However, a detailed molecular understanding of the signals that
mediate this communication and the role of such communication in circuit development have not been fully
addressed. In my preliminary studies, I have identified the astrocyte-derived synaptogenic factor,
Hevin/Sparcl1, as a direct signal to microglia. Hevin is proteolytically cleaved just after eye opening which
coincides with a period of net decrease in thalamocortical synapse density. Additionally, Hevin’s C-terminal
binds and activates TLR4 leading to an increase in the expression of microglia TLR2. Using a recently
developed TLR2 knock in reporter line, I further show that TLR2 expression is restricted to microglia in the
developing cortex and can be used to identify two populations of microglia, TLR2-low vs. TLR2-high.
Intriguingly, I found that TLR2-high microglia have a high lysosomal compartment suggesting they represent a
more phagocytic population of microglia. Based on these findings, this proposal will test the hypothesis
that astrocyte secreted Hevin is cleaved in a sensory experience dependent manner to produce a C-
terminal fragment that is required for synapse development. I further propose that Hevin signals locally
through microglia expressed TLR4 to prime a subpopulation of the surrounding microglia to be more
phagocytic marking them with an increased expression of TLR2. This hypothesis will be tested in two
aims. Aim 1 will elucidate the role of Hevin proteolytic cleavage in synapse development and plasticity and
link this event to sensory experience. Aim 2 will define a molecular mechanism that links processing of an
astrocyte-derived synaptogenic factor with heightened microglia mediated synapse elimination. The findings
from this study will for the first time identify a molecular signaling pathway from astrocytes to microglia that
coordinates astrocyte and microglia function in response to sensory experience.

Public health relevance
PROJECT NARRATIVE Proper wiring of neuronal circuits during critical developmental periods requires tight control of formation and the elimination of synaptic connections in response to sensory experience changes. Astrocytes and microglia are two glial cell types that have been shown to play central roles in synapse formation and synapse elimination, respectively. I aim to investigate how signals derived from astrocytes that instruct synapse formation are modified by synaptic activity driven by sensory experience and instruct microglia to orchestrate synapse formation and elimination processes.